DP22-001 Coordinating Center (CC) for Determining the Long-Term Effectiveness of Real World structured lifestyle interventions in preventing type 2 diabetes

PROJECT SUMMARY/ABSTRACT
RTI International proposes to serve as the Coordinating Center (CC) for the Centers for Disease Control and
Prevention (CDC)-funded research network of study sites to assess barriers and facilitators for enrollment
and sustained participation in the National Diabetes Prevention Program (NDPP) and Medicare DPP
(MDPP) and to determine the long-term effectiveness and cost-effectiveness of the programs. As the CC for
this opportunity, RTI will facilitate collaboration to achieve the program objectives by providing scientific and
statistical expertise, as well as offer logistical and data management support. As the CC, RTI will contribute
to the design, development, and management of a centralized protocol with common core data elements and
establish study operations to efficiently monitor progress. RTI will also collect, manage, analyze, report, and
disseminate the research findings. Specifically, we propose to enhance network efficiency and productivity
by providing logistical and operational support, scientific expertise, and consensus building; ensure
adherence to standardized study protocols by developing and sustaining a central database of harmonized
data; and determine the long-term effectiveness of the NDPP/MDPP by providing analytical and statistical
support to the sites and by conducting cross-site analyses.
RTI has over 35 years of experience as a CC for clinical research networks, providing scientific expertise
and administrative and operational support. In addition, we will draw on our extensive experience collecting
and analyzing data as part of researching, evaluating, and supporting implementation of the NDPP and
MDPP programs that we will draw on in execution of this CC opportunity. Our team will be headed by Dr.
Sara Jacobs, an established principal investigator of the National Institutes of Health–funded Sickle Cell
Disease Implementation Consortium Data CC, who also is an experienced researcher and evaluator of the
NDPP/MDPP, having led projects for both CDC and the Centers for Medicare & Medicaid Services. In
addition, the RTI team offers six experts: Dr. Thomas Hoerger (economist and NDPP/MDPP expert), Dr.
Jennifer Popovic (electronic health record clinical data extraction), Benjamin Allaire (claims data and control
group construction), Dr. Jamie Humphrey (social determinants of health), Karen Strazza (qualitative data),
and Whitney Battestilli (database construction). Together, this team brings the expertise to support and guide
all aspects of the NDPP/MDPP research network.

Public health relevance
PROJECT NARRATIVE The Centers for Disease Control and Prevention (CDC) aims to create a research network of study sites to assess barriers and facilitators for enrollment and sustained participation in the National Diabetes Prevention Program (DPP) and Medicare DPP and to determine the long-term effectiveness and cost-effectiveness of the programs. The Coordinating Center (CC) will facilitate scientific collaboration to achieve the program objectives by providing scientific and statistical expertise and logistical and data management support. Specifically, the CC will contribute to the design, development, and management of centralized protocols with common core data elements and will establish study operations to efficiently monitor studies and to collect, manage, analyze, report, and disseminate the research findings.